Generational Overlap: Changing Demography, Shared Lifetimes, and Family Resources

Project Summary/Abstract
Kinship ties form the bedrock of societies and provide meaning in terms of roles, obligations, and responsi-
bilities. Generational overlap in the form of shared lifetimes represents a fundamental condition guiding
whether and how kin relationships may develop and the extent to which resources are shared. Yet, we know
little about the prevalence, duration, or life course timing of generational overlap, how it varies by socioeco-
nomic status, and how it may potentially influence individual health and wellbeing. Generational overlap is con-
sequential because it offers an important perspective for observing the demographic constraints on multigener-
ational family investments in children. We propose to provide new information about the overlap in shared life-
times for grandchildren and grandparents across two industrialized countries – the U.S. and Denmark. Both
countries have experienced declines and delays in fertility, lengthening life expectancies, and notable educa-
tional expansion in the 20th century, but these have occurred on different timelines, to different degrees, and
within different social policy regimes. We use harmonized data from the Panel Study of Income Dynamics, the
Danish population register, the Add Health Parent Study and the Survey of Health, Aging, and Retirement in
Europe to evaluate generational overlap and its implications across historical time. We consider three genera-
tions – grandparents (G1), parents (G2), and grandchildren (G3) and focus on grandparents born since 1912.
We address three specific aims: 1) Provide a descriptive portrait of the prevalence and length of generational
overlap for grandparents (G1) and grandchildren (G3) in the U.S. and Denmark using an innovative age-pe-
riod-cohort approach; 2) Explicate the role of educational expansion in shifting generational overlap, including
the specific case of within-family intergenerational mobility where diminished generational overlap may be an
unanticipated `cost' of intergenerational mobility; 3) Document the social class gradient in grandparents' life
course position (employment status, health, and proximity to kin) arising from the timing and duration of gener-
ational overlap and describe the intergenerational exchanges of time, money, and care that result – and for
Denmark, consider subsequent health/wellbeing for G1-G3. We attend to further variation by gender, family
structure, and (for the U.S.) race/ethnicity. In sum, shared lifetimes among grandparents, parents and grand-
children represent a key aspect of how kinship ties shape individual life courses. We explore how the duration,
quality, and consequences of these shared lifetimes are shaped by demographic processes across genera-
tions. This project will be led by an outstanding team of established collaborators who are leaders in the fields
of family demography and social inequality and who possess the methodological skill and expert knowledge of
each data source to achieve the study's aims. These findings have important implications for the intergenera-
tional transmission of inequality, as well as potential resource demands on governments and families.

Public health relevance
Project Narrative/Public Health Relevance Statement Changing fertility and mortality patterns influence the extent of generational overlap (i.e., shared lifetimes among family members). This is important because both children and elders benefit from intergenerational kin relationships and resource sharing, which may offset the need for public resources and potentially reduce inequality. In this project, we provide new data on generational overlap between grandparents and grandchildren, comparing the U.S. and Denmark and considering variation by socioeconomic status and across demographic sub-groups.